Research Flow Cytometer for Research and Education Capacity Building at St. Mary's University

Project Summary/Abstract
The goal of this proposal is to acquire a Beckman Coulter CytoFlex instrument for flow cytometry that
will be housed at St. Mary’s University in a collaborative lab space to support scientific research and
educational projects in basic, translational, and biomedically-related disciplines. Flow cytometry is a
useful technique for the analyses of cells and particles. The number of parameters that can be rapidly
assessed from cells or particles in solution is wide ranging and includes counting cells or particles,
assessing size, cell cycle stage, protein expression, and modifications, among others. The major,
minor, and future users of the instrument include research-active faculty in the department of
biological sciences with a variety of research interests that include immunology, cancer, microbiology,
genetics, and cardiovascular disease. Important users also include students enrolled in core biology
and biochemistry coursework and advanced biology classes like Toxicology and Immunology &
Infection that offer course-based undergraduate research experiences (CURE). The CytoFlex
instrument has been selected because 1) it is incredibly versatile and can accommodate the diversity
of research and users at our institution; 2) it is easy to use and maintain, without specially-trained
staff; and 3) it will expose undergraduates to instrumentation that is commonly found in state-of-the
art research and clinical diagnostic laboratories, thus better preparing them for the biomedical
workforce. Faculty and student access to this kind of technology will benefit all users, increase
research productivity, foster the development of St. Mary’s biomedical research culture, improve
STEM education, and be important for recruiting and retaining future faculty.

Public health relevance
Project Narrative St. Mary’s University is a Hispanic-serving institution in San Antonio, TX that serves students primarily from South Texas. Despite being a resource-limited institution receiving well under $6 million in research funding from the National Institutes of Health, it has a strong record of developing the biomedical workforce and preparing graduates for STEM and health careers. Access to a state-of- the-art scientific flow cytometry instrument that can assess cells or particles for wide range of characteristics, will invigorate current research at St. Mary’s; contribute to opportunities for new research projects; stimulate collaborations; attract, recruit, and retain new faculty to St. Mary’s; develop critical thinking and technical skills in students; and enhance STEM education.